Polyclonal Bi-Specific Vectored ImmunoTherapy to Functionally Cure HIV Infection

Project Summary / Abstract
This proposal describes the framework of a DP1 grant for Alejandro B. Balazs, PhD.
Dr. Balazs is currently an assistant professor at Harvard Medical School and a principal
investigator at the Ragon Institute of MGH, MIT & Harvard. Dr. Balazs' research is focused on
engineering the immune system via gene transfer as a novel means of creating protection against
infectious disease. This proposal represents an entirely new research direction for his laboratory
and is focused on the creation of vectors capable of producing multi-specific polyclonal antibodies
in vivo which can neutralize both the highly-mutable HIV-1 virus as well as addictive substances.
These will test the hypothesis that engineered polyclonal immune responses can permanently
suppress HIV-1 infection more effectively than separate antibodies. The proposal aims to test this
concept by first comparing multiple designs of vectors engineered to produce multi-specific
antibodies that can both neutralize HIV in a series of cell-based assays. Designs with optimal
activity will advance to testing in both mouse and non-human primate models to identify those
with maximal expression potential in vivo. Optimal designs will be tested in animal models of HIV-
infection. These experiments aim to determine whether polyclonal engineered immune responses
can more effectively control HIV replication than multiple individual antibodies while resisting the
emergence of escape mutants to achieve a functional cure of HIV infection in people with
substance use disorders. Such a finding would have profound implications for treatment of HIV in
the context of substance use disorder offering an improved therapeutic intervention against HIV,
particularly for people who are unable to comply with existing antiretroviral drug regimens.
Moreover, this technology will also test the development of a single therapeutic intervention
targeting both HIV and addictive substances, to improve health outcomes for people living with
HIV with underlying substance use disorders, consistent with the mission of NIDA and the NIH.

Public health relevance
Project Narrative The ability of HIV to escape from sub-optimal dosing of existing antiretroviral drugs and avoid neutralization by the immune system are two of the greatest challenges facing the development of effective strategies to control and eliminate infection. This proposal seeks to develop a novel class of drugs that can both neutralize HIV while simultaneously reducing the activity of addictive substances. Using this approach, we seek to create functional cure of HIV infection and substance use disorder with a single product administration.